Hypercalciuria and Abnormal Bone in the Genetic Hypercalciuric Stone-Forming Rats

ABSTRACT
Most patients who form calcium-containing kidney stones are hypercalciuric (excess calcium in urine), compared
with non-stone formers. These patients are often in negative calcium (Ca) balance in that they excrete more Ca
in their urine than they absorb from their diet, indicating a net loss of total body Ca. The source of the excessive
urine Ca (uCa) is almost certainly the skeleton, the largest Ca repository in the body. Indeed these patients often
have a reduction in bone mineral density, clinical osteoporosis, decreased bone strength and an increase in the
rate of bone fracture. The primary endpoint for successful treatment of patients with Ca-containing kidney stones
is a decrease in stone recurrence rate. Equally important, and often not as well recognized, is maintaining and
improving the patient's bone mineral density (BMD) and bone quality. To study idiopathic hypercalciuria (IH) in
ways that are impossible in man, we developed an animal model of this disorder. Through >100 generations of
successive inbreeding of the most hypercalciuric SD rat progeny, we established a strain of rats that now
consistently excrete ~8-10 times as much uCa as the founder SD rats. All of these rats spontaneously form
kidney stones, and are termed Genetic Hypercalciuric Stone-forming (GHS) rats. In common with patients with
IH, GHS rats have normal serum concentrations of Ca and 1,25D, increased intestinal Ca absorption, enhanced
bone resorption, decreased renal tubule Ca reabsorption, and hypomineralization of bone with weakened
mechanical properties. The overall goal of this proposed research project is to use the GHS rats to study the
relationship of hypercalciuria to BMD and bone quality. We propose to determine if increased expression of
vitamin D receptor (VDR) is responsible, at least in part, for the hypercalciuria and decreased BMD and bone
quality in the GHS rats. We will then determine if pharmacologic interventions to reduce hypercalciuria will
improve BMD and bone quality. We propose the following Specific Aims: 1. Test the hypothesis that the
decreased BMD and bone quality in the GHS rats, compared to the founder SD rats, is due to an increased
abundance of VDR in both osteoblasts and osteoclasts, resulting in an alteration in function. 2. Test the
hypothesis that hypercalciuria, stone formation, reduced BMD and bone quality in the GHS rats can be improved
by pharmacologic treatments, including bisphosphonates, RANKL ligand inhibitor and sclerostin inhibitor,
directed toward reducing hypercalciuria. Results from these studies may lead to future clinical studies to reduce
hypercalciuria and recurrent stone formation and improve bone quality.

Public health relevance
NARRATIVE Our genetic hypercalciuric stone-forming rats are hypercalciuric, spontaneously form calcium-containing kidney stones, and have reduced bone mineral density and bone quality. We will use these rats as a model of idiopathic hypercalciuria in humans to study the relationship between hypercalciuria and bone mineral density and quality, as well as test potential pharmacologic interventions to improve bone. Our findings from these cellular and animal studies may lead to a substantial effect on treatment paradigms that will not only reduce recurrent stone formation but also improve bone quality in hypercalciuric patients.